Mechanisms and functional role of mitochondria in eosinophilic esophagitis

Project Summary
Eosinophilic esophagitis (EoE) is a chronic food allergen- and immune-mediated disease that exerts a significant
clinical and financial burden worldwide. Interleukin (IL)-13 is an essential mediator of EoE due to its pleotropic
effects on esophageal inflammation and tissue remodeling. We have identified IL-13 as a critical mediator of
increased mitochondrial mass in esophageal epithelial cells. We further demonstrate that IL-13-mediated
alterations in mitochondrial mass are dependent upon JAK/STAT signaling and contribute to EoE-associated
epithelial remodeling. These findings support our overarching hypothesis that IL-13 in the EoE inflammatory
milieu activates STAT signaling in esophageal epithelium to drive alterations in mitochondrial biology that
promote EoE pathogenesis. To test this hypothesis, we will define the direct molecular mechanisms through
which IL-13 signaling regulates mitochondrial biology (Aim 1) and the functional significance of these findings
with regard to EoE-associated tissue remodeling (Aim 2). The proposed studies will illuminate the IL-
13/STAT/mitochondria axis as a novel player in EoE pathobiology. The research proposal, coupled with the
tailored training plan, will provide outstanding career and professional development opportunities for the
applicant under the guidance of the co-mentors who have relevant expertise in esophageal biology (Whelan)
and mitochondria (Elrod).

Public health relevance
Project Narrative Eosinophilic esophagitis (EoE) is an emerging form of allergic inflammation that exerts a significant clinical and financial burden worldwide. Here, we will define the impact of EoE inflammation on mitochondrial biology, as well as the functional significance of mitochondria in EoE. These studies have great potential to advance our understanding of EoE pathobiology, which may then translate to improved clinical care of EoE patients.